Targeting SOX2 expression in prostatic regeneration and enlargement

PROJECT SUMMARY AND ABSTRACT
Age-related benign enlargement of the prostate gland (BPH) and associated lower urinary tract symptoms
(LUTS) is the most common urologic condition in aging men affecting 70% of men over the age of 60. Despite
initial success of therapies aiming to treat LUTS, these interventions are long -term, expensive, and
discontinuation results in recurrent symptoms. Identifying and incorporating new therapeutic strategies f or
clinical use to effectively treat BPH is necessary. Recent data from our lab and others has implicated stem cell
transcription factor SOX2 in prostate regeneration pathways that play a role in prostate enlargement during
BPH. SOX2 is highly expressed in BPH tissue and a lineage tracing experiment showed a SOX2-positive cell
population survives prostate involution and can derive SOX2-negative luminal epithelial cells during prostate
regeneration. Despite this evidence that SOX2 contributes to prostate gro wth/regeneration, pharmacologically
targeting SOX2 expression in this context has not been explored. Data from a recent drug screening
experiment, single cell RNA-seq, and mining of meta-data implicate IGF1R signaling as an upstream regulator
of SOX2 transcription. Unpublished data shows a reduction of SOX2 transcript and protein after IGF1R
inhibition. Based on these unpublished results, we hypothesize that SOX2 is necessary for prostate
regeneration and that decreasing SOX2 expression through inhibition of IGF1R will prevent prostate
regeneration and improve current therapeutics for BPH.
The overall objectives for this proposal will address this hypothesis experimentally utilizing new model systems
and technology and provide training and professional development support to advance the candidate’s career
as an independent investigator. Addressing the hypothesis will utilize the following specific aims: 1) determine
the impact of SOX2 in prostate epithelial cell survival and prostate enlargement and lower urinary tract
dysfunctions of symptomatic BPH, and 2) delineate the mechanism for the reduction of SOX2 expression after
IGF1R inhibition. To accomplish the first aim, prostate epithelial cell survival will quantified in vitro after IGF1R
inhibition. To assess clinical relevance, a mouse model for symptomatic BPH will be utilized to assess prostate
enlargement and voiding symptoms following IGF1R inhibition. To achieve the second aim, a proteome
profiler, Western blotting, and siRNA will be utilized to interrogate the mechanism mediating the IGF1R/SOX2
regulatory pathway. To accomplish the proposed career development objectives, the candidate will 1) establish
unique research position by developing technical skills in BPH-LUTS model systems and drug design and
development, 2) cultivate skills necessary to facilitate a career as an independent researcher including formal
training in mentorship and grant writing, and 3) strengthen research communication skills and network in the
field of benign urology. This proposal will provide the resources and training necessary to assess the role of
SOX2 in prostatic disease as a career development project.

Public health relevance
PROJECT NARRATIVE Benign prostatic hyperplasia (BPH) affects 70% of men over the age of 60, and current interventions are not curative. Stem cell transcription factor SOX2 has been linked to prostate regeneration and BPH, but its role as a potential pharmacologic target has not been established. In the proposed study, we will investigate the role of SOX2 in BPH and define the mechanistic link between SOX2 and IGF signaling; these data will provide new insight into BPH etiology and have high potential to improve current therapeutics for BPH.